Spectroscopy of Fe-S Cluster Proteins -- Information for Structure and Function

GM65440 Renewal Resubmission Project Summary
The element iron plays an enormous role in biology, including electron transport reactions
(ferredoxins), oxygen transport and storage (hemoglobin and myoglobin), catalysis
(nitrogenase, P-450, hydrogenase, and thousands of other enzymes), small molecule sensing
(especially O2, CO, and NO), and DNA processing and repair. The health-relatedness of a
better understanding of the structure and function of biological Fe is clear.
The general theme of research in the Cramer lab involves the use spectroscopy as a tool
for characterization of metals in biological systems. Much of this work involves the application
of synchrotron radiation x-ray sources. Thanks to enormous improvements of these sources,
experiments with exquisite sensitivity can now be conducted on dilute Fe samples. These
include the technique Nuclear Resonance Vibrational Spectroscopy (NRVS), which is sensitive
to the motion of 57Fe in a sample. Another new technique, nuclear-resonant time-domain
interferometry (NR-TDI) can probe motion of all atoms in a sample. The x-ray experiments at
international facilities are complemented by IR and Raman measurements at the home lab.
The goals for the next 4 years can be divided into 3 main themes:
· better understanding of the catalytic intermediates of the enzymes that process hydrogen –
[NiFe] and [FeFe] hydrogenases,
· information about structural changes that occur when Fe-S cluster proteins sense their
environment, including mitoNEET and NAF-1, two health-related proteins which sense and
communicate pH and redox status, and
· characterization of protein dynamics in extremophiles (organisms that live at extremes of
temperature, pressure, pH and other stressors) using the protein rubredoxin as a model
system and using NRVS and NR-TDI to respectively measure the motion of Fe or the entire
protein.
The overall vision of this research program is to use spectroscopic methods to better
understand how iron is used in important proteins, in ways that complement the information
that can be gathered from diffraction and microscopy. In the course of research on specific
topics, spectroscopic techniques such as NRVS will be further developed for the bioinorganic
community. The novel NR-TDI technique will be assessed as a complementary probe of
dynamical information about proteins.

Public health relevance
Project Narrative The element iron plays an enormous role in biology, and we plan to study how iron contributes to catalysis (in hydrogenases), to pH and small molecule sensing (in NEET proteins), and to electron transport reactions (in rubredoxins). Using very bright x-ray beams from synchrotron radiation sources, we will study the vibrations of iron in the above systems, and this will provide structural information about how these proteins work. Information and insights gained from this project will help us better understand the biological chemistry of iron, so that we can learn from Nature to create a more efficient and healthier society and perhaps alleviate the damage from cancer and other diseases that occurs when some of these enzymes fail.